Preclinical studies of a heroin/morphine vaccine for opiate addiction

DESCRIPTION (provided by applicant): This application is submitted in response to PAS-08-061 Long-acting, sustainable therapies for opiate addiction. A heroin/morphine addiction treatment vaccine candidate has been developed which appears in preliminary studies to be highly effective in rats. The purpose of this proposal is to further characterize the immunogenicity, mechanism of action and efficacy of this vaccine in rats and mice and assess its readiness for clinical trials. Despite the availability of effective pharmacotherapies for treating heroin addiction, fewer than 1 in 5 opiate addicts in the U.S. choose to use these. Among the limitations of currently available medications are their relatively short duration of action, the need for tight regulation of dispensing, side effects or interference with the therapeutic use of other opiates, and the perception of trading one addiction for another. New medications with mechanisms of action distinct from those already available could provide additional treatment options, and a long duration of action could increase their appeal and ease of use. Vaccines for nicotine and cocaine addictions are in clinical trials and preliminary data suggest efficacy. These vaccines reduce or slow the distribution of the target drug to brain, attenuating their effects. We (Anton lab) recently developed a highly immunogenic second-generation vaccine (morphine conjugated to tetanus toxoid; M-TT) directed against heroin and each of its active metabolites (6-MAM, morphine, morphine-6- gluc). Vaccination with M-TT elicits high concentrations of high affinity antibodies, and robustly blocks heroin or morphine self- administration in rats. We propose an integrated series of (Aim 1) immunologic, (Aim 2) pharmacokinetic, (Aim 3) behavioral and (Aim 4) safety studies to evaluate the clinical potential of this vaccine in rats and mice. Because heroin pharmacokinetics is complex, particular attention will be paid to characterizing and quantitating M-TT effects on heroin and each of its active metabolites. These data will allow us to understand how the binding of each of these moieties by antibody relates to vaccine efficacy, and will provide biomarkers that can be used to asses the adequacy of immunization in future clinical trials. The general hypotheses to be tested are that 1) M-TT immunogenicity can be further enhanced, and that M-TT remains immunogenic even in the presence of heroin, 2) M-TT acts through multiple complementary pharmacokinetic mechanisms involving heroin and each of its active metabolites, 3) M-TT attenuates heroin and morphine self-administration, and opiate-induced changes in brain reward thresholds over a range of clinically relevant opiate doses, and 4) M- TT is safe and does not itself precipitate opiate withdrawal.

Public health relevance
PUBLIC HEALTH RELEVANCE: There are an estimated 15 million opiate addicts worldwide and 1.2 million heroin addicts in the U.S. Heroin addiction is associated with disruption of crime, social disruption, and severe health consequences including the spread of HIV and hepatitis C. There are several medications already available or the treatment of heroin addiction, including methadone, buprenorphine and naltrexone. Although these have all been shown to be effective, fewer than 1 in 5 addicts in the U.S. choose to use them because of real or perceived drawbacks that result in low acceptability. The vast majority of heroin addicts are therefore not receiving treatment. Alternative medications, which could provide a greater choice of therapeutic options, might increase the number of addicts electing and staying in treatment. A non-addictive and long-acting medication which obviates the need for daily clinic visits would be of particular interest. Vaccines have been developed for the treatment of nicotine and cocaine addiction, and are in early clinical trials. These vaccines stimulate the production of antibodies that bind the drug and reduce the amount of drug reaching the brain, thereby reducing its addictive effects. Advantages of vaccines for addiction treatment are that they are safe, non-addictive, and have a very long duration of action (months) which can be extended as needed with additional booster doses. We have developed a heroin vaccine that stimulates production of high levels of antibodies and that can block some of the key addictive effects of heroin or morphine in rats. The proposed study will further characterize this vaccine, over a wide range of clinically relevant heroin doses, to assess whether it is suitable for advancement to clinical trials. The importance of this work is in providing an additional type of medication for those opiate addicts or abusers who find the currently available options unacceptable, or possibly for use in addition to existing medications to enhance their efficacy. PUBLIC HEALTH SIGNIFICANCE There are an estimated 15 million opiate addicts worldwide and 1.2 million heroin addicts in the U.S. Heroin addiction is associated with disruption of crime, social disruption, and severe health consequences including the spread of HIV and hepatitis C. There are several medications already available or the treatment of heroin addiction, including methadone, buprenorphine and naltrexone. Although these have all been shown to be effective, fewer than 1 in 5 addicts in the U.S. choose to use them because of real or perceived drawbacks that result in low acceptability. The vast majority of heroin addicts are therefore not receiving treatment. Alternative medications, which could provide a greater choice of therapeutic options, might increase the number of addicts electing and staying in treatment. A non-addictive and long-acting medication which obviates the need for daily clinic visits would be of particular interest. Vaccines have been developed for the treatment of nicotine and cocaine addiction, and are in early clinical trials. These vaccines stimulate the production of antibodies that bind the drug and reduce the amount of drug reaching the brain, thereby reducing its addictive effects. Advantages of vaccines for addiction treatment are that they are safe, non-addictive, and have a very long duration of action (months) which can be extended as needed with additional booster doses. We have developed a heroin vaccine that stimulates production of high levels of antibodies and that can block some of the key addictive effects of heroin or morphine in rats. The proposed study will further characterize this vaccine, over a wide range of clinically relevant heroin doses, to assess whether it is suitable for advancement to clinical trials. The importance of this work is in providing an additional type of medication for those opiate addicts or abusers who find the currently available options unacceptable, or possibly for use in addition to existing medications to enhance their efficacy. __SpecificAimsTextDelimiter__ SPECIFIC AIMS This application is submitted in response to PAS-08-061 "Long-acting, sustainable therapies for opiate addiction" which solicits proposals to study "pharmacotherapies that do not require daily dosing... and with the potential to overcome compliance issues with currently available treatments". The long-term goal of this work is to develop and assess the potential clinical role of vaccines for the treatment of opiate addiction. The immediate goal is to use an existing, highly immunogenic heroin/morphine vaccine candidate (M-TT) to 1) study the mechanisms by which vaccination alters opiate pharmacology, 2) investigate its range of immunologic, pharmacokinetic and behavioral effects in rats, and 3) advance this vaccine to readiness for clinical trials. Opiate addiction remains an important problem in the U.S. and worldwide despite the availability of effective agonist and antagonist treatment medications. Fewer than 1 in 5 opiate addicts in the U.S. choose to use available therapies because of their real or perceived limitations. In addition, many developing countries cannot afford currently available medications and the close supervision they require. Addiction vaccines target the drug rather than the brain, and represent a mechanistically distinct approach to addiction treatment; with a long duration of action (months) and which address many of the limitations of currently available therapies. These vaccines elicit drug-specific antibodies which bind the addictive drug, reduce or slow drug distribution to brain, and attenuate a wide range of addiction-related behaviors. Vaccines for nicotine and cocaine addictions are now in Phase II-III clinical trials with early evidence of efficacy. The intent in developing an opiate vaccine is not to replace current medications, but to complement them and extend their reach by providing an alternative for those who do not tolerate agonist or antagonist therapy, or who find it unacceptable. In addition, heroin is a largely inactive prodrug with pharmacokinetic properties (3 active metabolites which have a wide range of clearance and distribution rates) that are considerably more complex than the drug targets of other addiction vaccines. Addressing and characterizing vaccine/heroin interactions should serve to deepen our understanding of addiction vaccine action, efficacy, limitations and clinical potential. The focus of this proposal is a morphine-tetanus toxoid conjugate vaccine (M-TT) directed against heroin and each of its active metabolites 6-monoacetylmorphine (6-MAM), morphine and morphine-6-glucuronide (M-6- gluc). M-TT elicits reproducibly high titers of high affinity antibodies against each of these opiates, and robustly blocks the reacquisition of heroin and morphine self-administration in rats. The elicited antibodies bind all active metabolites of heroin, while sparing clinically important off-target opiates (ss-endorphin, leu-enkephalin, methadone, buprenorphine, naltrexone) to avoid side effects and allow the therapeutic use of these medications if needed. This favorable range of specificities should make it possible to use of M-TT either alone or in combination with other available opiate treatment medications to enhance their efficacy. M-TT pharmacology will be studied in rats using an integrated series of immunologic, pharmacokinetic, behavioral and toxicologic studies to clarify its spectrum of effects and mechanism of action. Aim 1 (immunology) will test the hypotheses that optimizing M-TT vaccination schedules can further enhance its immunogenicity while simplifying the vaccination regimen, and that concurrent heroin administration does not reduce vaccine immunogenicity. Aim 2 (pharmacokinetics) will examine M-TT effects on heroin and metabolite pharmacokinetics using a variety of clinically relevant dosing regimens. This Aim will test the hypothesis that M-TT acts by altering both heroin and metabolite (6-MAM and morphine) pharmacokinetics. Aim 3 (behavior) will explore M-TT's effects on heroin reinforcement and dependence. It will test the hypotheses that M-TT blocks ongoing heroin self-administration (vaccination initiated after self-administration is established) and opiate reward and withdrawal as measured by changes in brain reward thresholds. Aim 4 (toxicology) will examine the safety of M-TT. It will test the hypotheses that dependent rats can be vaccinated without precipitating opiate withdrawal, and that M-TT is free of other side effects whether administered with or without concurrent heroin. Together, these Aims will increase our understanding of heroin vaccine action and provide a comprehensive data set to assess M-TT's suitability and readiness for clinical trials. The significance of this work lies in the introduction of a mechanistically distinct opiate addiction therapy that can be used, alone or in combination with existing therapies, to provide a novel additional treatment option.